RANDOMIZED TRIAL OF VITAMIN A SUPPLEMENTATION FOR ELBW INFANTS

Examines whether the achievement and maintenance of physiologic blood and tissue levels of vitamin A in infants with birth weight less than 1 kg will reduce the prevalence of chronic lung diease, a major cause of neonatal morbidity.